Dynamical Diffraction Analysis for 3D Electron Crystallography

Project Abstract
This Phase II SBIR project aims to advance microcrystal electron diffraction (microED) methods, which combine
the advantages of single-crystal X-ray crystallography with the flexibility of working with smaller crystals, but they
do not routinely produce results of quality comparable to X-ray crystallography. Challenges include inefficiencies
in data acquisition and analysis, the absence of dedicated methods for solving the phase problem in the presence
of electron diffraction (ED)-specific systematic effects, and a lack of integration between software tools, resulting
in information loss and the selection of suboptimal strategies by researchers to circumvent software issues. The
overarching goal of the project is to enhance the usability of ED by developing innovative and integrated software
solutions that address these challenges.
We will improve data collection efficiency by innovating new data acquisition techniques, enabling faster
selection of crystals and their quality evaluation with higher confidence. This will be achieved by calibrating
hardware features affecting the experiment and by developing new indicators for detecting crystals on cryoEM
grids. We will also advance ED data analysis by developing methods for indexing, integrating, and scaling
electron diffraction patterns, including handling multiple scattering effects, and accelerating data throughput with
GPU computing for real-time analysis. Furthermore, we will develop ED-specific phasing methods to address
data insufficiency problems common in the field and to facilitate optimal structure refinement for better agreement
between data and chemical models. This will involve dynamical refinement, determination of absolute
configuration, dimensionality reduction methods for clustering isomorphous samples, and developing corrections
for many systematic effects that are currently not modeled or are modeled suboptimally. Finally, we will equip
users with tools for monitoring the progress and performance of complex experiments, instrument data analysis,
and automating data preparation for deposition in scientific repositories.
The outcome of the SBIR Phase II will be an easy-to-use, GPU-optimized, complete crystallographic package
for microED, validated across a broad range of experimental conditions with submodules tailored to address
specific scientific problems, e.g., analysis of small organic molecules or analysis of large macromolecules. This
user-friendly, efficient, versatile software will be ready for commercial distribution and will benefit researchers
who require atomic-level descriptions of chemical compounds, both in industry and academia.

Public health relevance
Project Narrative Structures of small molecules and macromolecules are crucial for understanding biological and chemical processes at the molecular level and for guiding drug and treatment design. However, X-ray structure determination, particularly for new compounds, is challenging because the techniques require relatively large crystals to succeed. Our proposal aims to develop innovative computational approaches to enhance the robustness of microcrystal electron diffraction (microED) that can use nanocrystals, enabling molecular structure determination for challenging projects.